Administrative Core

PROJECT SUMMARY
Administrative Core
TUFCCC: Grace X. Ma, PhD (Contact PI) and Camille Ragin, PhD, MPH (MPI)
HC: Olorunseun Ogunwobi, MD, PhD (Contact PI) and Joel Erblich, PhD, MPH (MPI)
The Administrative Core (AC) of the TUFCCC/HC Regional Comprehensive Cancer Health Partnership 2.0 (aka: SPEECH 2.0) builds on an established effective leadership, governance infrastructure and foundation of productivity and impact. Over the past 5 years, the Partnership directly supported 84 investigators, 56 cancer research projects, mentored 180 trainees (61% received career or education advancements) and engaged 50 community-based organization partners in cancer prevention activities. The overall goal of the AC for SPEECH 2.0 is to further enhance cancer health research infrastructure and our administrative leadership to provide vigorous scientific/programmatic oversight and integration of research projects, education/training, and community outreach and engagement activities to be conducted by the Partnership, ensuring high-quality standards of excellence and impact on advancing cancer research and prevention in urban and rural communities in PA, NJ and NYC (PNN) region. The AC’s functions include, but are not limited to, providing leadership, oversight, fiscal management, coordination, integration, and communication to support the Partnership’s day-to-day operations. The AC will ensure the efficient, effective, and synergistic performance of the proposed Partnership’s aims, throughout all of the projects, cores, and shared resources. The aims of the integrated TUFCCC/HC Administrative Core are as follows: Aim 1. Leverage the established organizational structure to enhance operational capacity and provide robust administrative and fiscal support for overall program activities of TUFCCC/HC Partnership cores and research projects. Aim 2. Facilitate and enhance communication and collaboration opportunities to promote team science among Partnership faculty, trainees, investigators, and program coordinators. Aim 3. Strengthen and maintain leadership infrastructure to ensure the integration of cores, projects, shared resources, as well as inter-institutional initiatives across Partnership and beyond. Aim 4. Establish and maintain sustainable infrastructure to support and ensure the competitiveness of the Partnership's research project portfolio. Aim 5. Direct and support continuous quality improvement using multiple metrics to inform decision-making in planning and evaluation across all cores and projects of the Partnership. Both institution leaders have and will continue to provide exceptional commitments to SPEECH 2.0. AC has been well established and integrated and will continue to be jointly led by experienced multidisciplinary cancer research leaders. The AC team demonstrated not only meaningful collaboration and significant accomplishments during SPEECH 1.0, but also strong a sustained commitment to our shared vision of advancing cancer research and prevention. In the next phase, the AC core will be committed to strengthening cancer research, professional development and collaborative innovation to promote excellence across all components of our Partnership.